Core of Advanced Platform Technologies Used for Remediation and Exploration

ABSTRACT
CAPTURE
Responding to newly discovered environmental contaminants requires novel analytical approaches.
The Core of Advanced Platform Technologies Used for Remediation and Exploration (CAPTURE) will
provide analytical capabilities to the four projects in the NC State Superfund Research Center to enable
rapid, comprehensive assessment of PFAS presence. CAPTURE is comprised of the Genomic
Sciences Laboratory (GSL), the Analytical Instrumentation Facility (AIF), and the Molecular Education,
Technology, and Research Innovation Center (METRIC) at NC State, which have over $25M in modern
instrumentation and are operated by more than 20 PhD-level, highly qualified personnel. These
capabilities provide CAPTURE with the ability to explore the diversity of scientific questions with a broad
range of measurements including RNA-seq, materials characterization, and mass spectrometry
analyses for the known and unknown per- and polyfluoroalkyl substances (PFAS). New methods and
reagents will result from this work which will enable and inform the entire scientific community about
PFAS in the environment. Additionally, CAPTURE will enhance interactions among Center projects and
other cores, increasing their impact by ensuring synchronization of exposure measurements and
increasing their value in decision-making, translation, and community engagement.

Public health relevance
NARRATIVE CAPTURE CAPTURE is an integrated core facility which will support four projects relating to different aspects of PFAS through the development and application of novel tools that will facilitate both untargeted and targeted PFAS analyses. These capabilities will be accomplished using platform technologies with novel analytical platforms and methods providing significantly improved limits-of-detection and novel algorithms to focus on fluorinated species. The application of these integrated and state-of-the-art technologies will help the Center define the role of PFAS in the environment and its affect on human health.